Enhancing capacity for Strategic and Applied Research Activities in Support of Control and Elimination of Neglected Tropical Diseases

PROJECT SUMMARY
The proposed project will be implemented in priority sub - African countries. Prioritization is
based on USAID’s list of target countries, though final selection of project countries will be done
in partnership for CDC.
The project seeks to strengthen national control programs for Neglected Tropical Diseases
(NTDs) in various ways. First, we will strengthen the evidence- base for public health action
through conduct of operational research with a focus on various aspects of NTD control and
elimination, including new therapies and diagnostic tools. Secondly, we will support staff of
national NTD programs to be exposed to new therapies and diagnostic tools by facilitating
attendance at relevant meetings, and visits to model countries to learn and share experiences.
Finally, the knowledge generated from the operational research and other interventions carried
out by the national NTD programs will be used to support the development of public health
policies to guide future programming and action.
The anticipated overall outcome of this project is reduced morbidity and mortality from NTDs,
primarily in Africa, but in the world at large.

Public health relevance
PROJECT NARRATIVE The project will serve to strengthen Neglected Tropical Diseases (NTD) Control and Elimination in Africa, by providing an evidence base and platform for action to control and elimination in Africa, thus reducing morbidity and mortality in the portion of the African population that is at risk for these diseases.